Etiology and impact of ethnic disparities in therapy-associated hepatotoxicity among children and adolescents treated for ALL

Project Summary
This proposal seeks to integrate clinical, demographic, metabolomic, and genomic data to advance our
understanding of ethnic disparities in treatment-related hepatoxicity (TAH) during induction therapy for pediatric
acute lymphoblastic leukemia (ALL). Improved treatment regimens for pediatric (ALL) have resulted in survival
rates exceeding 90%; however, nearly a quarter of patients experience TAH. Emerging evidence from our group
has identified striking ethnic disparities in the incidence of TAH. Specifically, Latino patients with ALL appear
particularly vulnerable to dose-limiting TAH, potentially compromising treatment efficacy during the critical initial
induction phase and contributing to well-established disparities in pediatric ALL relapse and survival. This
proposal pursues the central hypothesis that risk of TAH is greater in Latino patients as compared to non-Latino
patients due to a combination of inherited and potentially modifiable risk factors. Our preliminary data suggest
ethnic disparities in TAH incidence are exacerbated but not fully explained by ethnic variation in obesity and that
the abundance of key metabolites in the blood associated with liver function, which are likely influenced by
treatment exposures and inherited genetic variation, may serve as powerful biomarkers of TAH risk. Informed
by our preliminary data, the specific research aims of this Project will examine: 1) to what extent ethnic variability
in obesity and associated hepatic dysfunction contribute to ethnic differences in the incidence of TAH during
pediatric ALL induction therapy; 2) whether consistent and recognizable changes induced by ALL chemotherapy
in the metabolomic pathways involved in liver function are predictive of TAH; and 3) how genetic variation
modifies individual susceptibility to TAH. This Project, which is jointly led by investigators with expertise in
pediatric oncology (Drs. Huynh and Orgel) and molecular epidemiology (Dr. Brown), builds on the rich resources
available in the ethnically diverse, multi-institutional Reducing Ethnic Disparities in Acute Leukemia (REDIAL)
consortium. Leveraging the Retrospective (n=2,958) and Prospective (n=1,369) REDIAL Cohorts, this project
will systematically evaluate and follow an additional 600 newly diagnosed cases of pediatric ALL. Thus, this
innovative proposal will establish one of the largest prospective investigations of TAH in a multi-ethnic cohort of
pediatric patients with ALL. The comprehensive research plan outlined here will address key gaps in our
understanding of ethnic disparities in the incidence and etiology of TAH and serve as a unique resource of
preliminary data to support future research endeavors. Ultimately, we anticipate that this work will inform risk-
stratified approaches to safely deliver curative induction chemotherapy to Latino children and adolescents
treated for ALL to improve their overall survival.

Public health relevance
Project Narrative The proposed research, which builds upon existing resources to study an adverse consequence of cancer therapy, addresses key gaps in our understanding of treatment-associated hepatoxicity, an adverse event which disproportionally affects Latino patients. This study will combine demographic, clinical, metabolomic, and genomic data, with an emphasis on identifying novel biomarkers and modifiable therapeutic targets to reduce the burden of treatment-related toxicity among the most vulnerable pediatric patients with ALL. This avenue of research has the significant translational potential to inform the delivery of targeted interventions to patients at high risk for TAH, with the ultimate goal of reducing ethnic disparities in ALL treatment outcomes.